OXYGEN METABOLISM IMAGING WITH MODULATED SPECKLE IMAGING

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Our objective is to develop a single-platform instrument capable of blood flow and oxygen saturation imaging. We will apply this instrument to studies of cortical spreading depression in the rat cranial window model.